Integrating Information about Aging Surveys: Novel Integration of Contextual Data to Study Late-Life Cognition and Alzheimer’s Disease and Related Dementia and Dementia Care

Abstract
Building resources to make data from high value, publicly funded cohort studies widely accessible, (re)usable,
and interoperable is one of the National Institute on Aging's key milestones of the Alzheimer's Disease and
Related Dementia (AD/ADRD) research implementation. The Gateway to Global Aging Data is a data
platform developed to harmonize and disseminate data from the Health and Retirement Study and its
international network of studies (HRS-INS) to facilitate longitudinal analyses on aging across 47 countries.
Expanding on an already successful platform, this application aims to bring in newly available data on late-life
cognition and dementia, collected using the Harmonized Cognitive Assessment Protocol (HCAP), together with
other newly available data from core longitudinal interviews, self-completion questionnaire, Life-History
interviews, End-of-Life interviews, and the special COVID-19 surveys, to promote high-quality studies of late-
life cognition, mild cognitive impairment (MCI), and AD/ADRD. We will also integrate contextual data,
specifically, air pollution exposures, institutional and policy measures related to long-term care and end-of-life
care, and information about the COVID-19 pandemic. Air pollution is a modifiable risk factor for AD/ADRD yet
most research is from individual countries and focused on total particulate pollution. By newly estimating air
pollution from different sources at respondent addresses, we will enable interested researchers to investigate
the effects of exposures on cognitive decline, MCI, and AD/ADRD, across multiple countries. Similarly, the
utilization, cost, and quality of long-term care related to dementia are emerging areas of concern. Thus, we aim
to identify institutional and policy differences in formal long-term, informal, end-of-life, and dementia care for
the respondents of the HRS-INS. Finally, the COVID-19 pandemic has been devastating to older adults though
the full magnitude of its impacts has yet to be understood. Survey data from the HRS-INS can inform the
extent of the damage. As we grow our database with new measures and expand our user base, we seek to
redesign the technical implementation of our metadata extraction, contextual data integration, and data
management and dissemination application. Such investment in data infrastructure is justified when the data
are widely used to produce novel and meaningful new knowledge, insights on population health, including
AD/ADRD and dementia care, and ultimately policy innovations. To facilitate the widespread use of the
Gateway's resources, we will further strengthen user training and support by regularly organizing user
conferences and workshops in addition to our regularly scheduled webinars. By amassing this expansive
platform of high-quality information from the HRS-INS harmonized by subject-area experts, making these data
publically available, and conducting outreach to support use of these data, we anticipate that the Gateway will
lead to impactful discoveries on the risks, care, and costs of AD/ADRD globally.

Public health relevance
Project Narrative The Gateway to Global Aging Data is a data and information platform developed to facilitate longitudinal and cross-country analyses on aging, especially the Health and Retirement Study and its International Network of Studies (HRS-INS) around the world (19 surveys in 47 countries). The Gateway makes analyses of HRS-family surveys across time and countries much easier, lowering the costs of entry for new researchers and saving time and effort even for experienced researchers. The proposed expansion to include additional longitudinal surveys, the Harmonized Cognitive Assessment Protocol (HCAP), the COVID-19 surveys, and two new surveys in Brazil and Chile will help numerous interested researchers and thereby accelerate the speed of scientific discoveries in late-life cognition and dementia.